Kansas PKD Research and Translation Core Center

Project Summary – Overall
The Kansas PKD Research and Translation Core Center (RTCC) is comprised of an Administrative Core and
three innovative Biomedical Research Cores: Core 1: Biomarkers, Biomaterials, and Cellular Models; Core 2:
Rodent Models & Drug Testing; and Core 3: Clinical Research. The Kansas RTCC also offers an Educational
Enrichment Program and an internal Pilot Grant Program in partnership with the KU Cancer Center. The
mission of the PKD Center is to promote PKD research by providing both innovative and essential reagents,
biomaterials, and service to the national PKD research community for the advancement of our understanding
of disease mechanisms, the discovery of biomarkers and therapeutic targets and the development of clinical
trials to improve patient outcomes. The Specific Aims of the Kansas PKD RTCC are: Aim 1) To support PKD
researchers nationally by developing innovative biomedical research cores. This will be accomplished by
developing the expertise, reagents and resources required to bring the best new technologies to PKD research
to meet the needs of the greater PKD research community; by leveraging existing institutional shared
resources to expand our capability, efficiency, and effectiveness; and by developing tools to support clinical
research and establish collaborations both regionally and nationally to develop a multi-institutional ADPKD
clinical trials network. Aim 2) To develop a skilled, collaborative, multidisciplinary basic science and clinical
PKD research investigator base. This will be accomplished by building on our broad multidisciplinary research
base and continuing to recruit new investigators from outside the PKD field by offering an innovative pilot grant
program that will attract new investigators to the field, and by providing new investigators, nationally, with
research support for core services, new technologies, educational opportunities, and an open and collaborative
research environment that will help them succeed. Aim 3) To enhance the PKD research environment with
educational programs to support ongoing projects and to develop new research directions. The research
environment will be enhanced through a seminar program, Summer Student Enrichment Program, PKD lab
meetings, PKD methods workshops, Research Methods and Advanced Technologies Program, professional
development seminar series, patient-oriented activities, and by participating in the consortium-wide annual
symposium. Aim 4) To develop partnerships regionally and nationally and to build teams to serve as a
resource for the greater PKD research community. Inter-institutional partnerships will provide local and national
infrastructure support, new research technologies, increased numbers of patients involved in clinical trials, and
research collaborators for the development of new research opportunities by attracting investigators from other
fields into PKD research from collaborating sites within the PKD Research Consortium and with cooperating
institutions nationwide, broadening opportunities beyond what any single institution can provide.

Public health relevance
Project Narrative - Overall The Kansas PKD Research and Translation Core Center will provide the core services infrastructure and educational environment to support research in polycystic kidney disease as a part of the national effort to develop new reagents and essential biomaterials for biomarker discovery and drug target identification to advance new therapies for testing in clinical trials ultimately for improved patient outcomes.